Mechanisms of Toll/interleukin1 receptor (TIR) domain function in cell death and immunity

Project Summary
Organisms across the tree of life rely on innate immune systems to detect the presence of
pathogens and activate appropriate responses, often including cell death. Our research program
dissects mechanistic commonalities of cell death and innate immunity across kingdoms. We
propose that a deeper understanding of innate immunity powered by comparative biology will
enable rational engineering of the plant immune system, provide novel mechanisms for
controlling microbes, and will inform pharmaceutical interventions in humans.
Over the next 5 years, my research program will mechanistically dissect a conserved domain of
innate immune receptors: the Toll/interleukin-1 Receptor (TIR) domain. TIR domains were first
discovered in animal Toll-like receptors and in plant intracellular immune receptors in the 1990s,
and recently in prokaryotic anti-phage systems. In all of these systems, TIR domains are found
in diverse protein architectures that function in cell death and innate immune pathways via a
conserved enzymatic activity to process nucleotides such as NAD+. My lab discovered that plant
TIR domains are enzymes and defined TIR-produced small molecules that regulate bacterial
anti-phage immunity. Critical immediate goals for TIR biology include understanding: the
determinants and regulation of enzymatic function; the spectrum of nucleotide-derived small
molecule signals; their downstream receptors; and the consequences of NAD+ depletion.
Over the longer term, I envision that my research group will leverage a mechanistic
understanding of TIR biology across kingdoms to engineer plant immune systems and to
understand the basis of bacterial TIR-driven innate immunity. A fuller understanding of TIR
biology will have direct impacts on human health, especially mechanism of the SARM1 TIR
protein, which shares enzymatic products with plant and bacterial TIRs but regulates damage-
induced cell death in neurons. SARM1 is a plausible therapeutic target for traumatic brain injury
and neurodegenerative disease.
In no system do we fully understand the mechanisms and consequences of TIR function. NAD+
depletion, the diversity of small molecule signals produced, and regulation of immune receptors
all represent knowledge gaps that limit TIR-based solutions. TIR biology represents an
opportunity for studies across systems to drive creative solutions for engineering innate
immunity and cell death in plants, bacteria, and animals.

Public health relevance
Project Narrative Toll/interleukin-1 Receptor (TIR) domains are conserved enzymatic domains found in innate immune receptors and cell death regulators in prokaryotes, plants, and animals. The recently discovered enzymatic function of TIR domains is poorly understood but has broad implications across biological kingdoms and for human health. A full understanding of TIR biology should enable creative solutions such as: the discovery of novel programmed cell death-based antimicrobial strategies; engineering of the plant immune system for food security; and manipulation of TIR-based pathways in humans that regulate responses to traumatic brain injury and neurodegenerative disease.